Administrative Core

Administrative Core (AC)
Lead: Karl Deisseroth MD PhD
Project Summary
The Administrative Core of the U19 will 1) shoulder the complex burden of coordination and communication
across projects, cores, collaborators, and visiting scientists; 2) manage financial, administrative, approval, and
safety issues; and 3) will oversee and implement data sharing and dissemination. For a U19 seeking to break
technological barriers, while also teaching and training in existing technologies, and using all of these
technologies, a robust and well-integrated Administrative Core will be fundamental to rigorous, safe, stable, and
effective implementation.